Core A: Administrative Core

CORE A – SUMMARY
The Administrative Core (Core A) will oversee and coordinate all administrative and research activities within
this program. All project leaders have primary faculty appointments in the Gladstone Institute of Neurological
Disease (GIND), which Dr. Mucke has directed since its inauguration in 1998. His leadership of this institute,
joint appointments in the Department of Neurology and various graduate training programs at UCSF, and long
record of service on relevant national and international advisory committees put him in an excellent position to
lead this core. He has collaborated with Drs. Yadong Huang (Project 1) and Jorge Palop (Project 2) on
Alzheimer’s disease (AD) research for roughly two decades, as highlighted by many widely cited, coauthored
publications in this field, and recently recruited Dr. Ryan Corces (Project 3 and Core B) to Gladstone and UCSF.
For many years, he has also interacted closely with Drs. Katie Pollard and Alex Pico (Core B) through their
leadership roles in Gladstone’s Bioinformatics Core. The well-established relationships among project and core
leaders will greatly help Core A to accomplish its overall goal of overseeing, coordinating, and supporting studies
proposed in all projects and cores. This program project will focus squarely on AD and places great emphasis
on cohesiveness and collaborative interactions among projects. Core A will critically support and enforce these
features and help ensure that our program not only addresses truly important biomedical problems, but also
creates diverse opportunities for scientific growth and advancement in AD-relevant research for all of its
members, ranging from graduate students and postdoctoral fellows to junior and senior faculty. Specifically, Core
A will develop and implement program-wide procedures to ensure optimal levels of scientific rigor, data safety,
cost effectiveness, and accountability across all four projects and the scientific core; encourage and facilitate
collaborative interactions among all project and core leaders as well as between program members and other
groups with related interests at Gladstone, UCSF, and beyond; survey relevant resources and fields of research
and alert project and core leaders to conceptual or technological developments that could enhance the pursuit
of their specific aims; form an external advisory committee and arrange regular meetings to review the program
and provide constructive feedback to all project and core leaders; prepare progress reports; coordinate
publications among program members; and collaborate with Core B to ensure the efficient dissemination of
program-generated data, reagents, and research findings to the broader scientific community.